Regulation of Pathologic Inflammasome Responses to SARS-CoV-2

Project Summary
Acute respiratory distress syndrome (ARDS) causes COVID-19 fatalities and is linked to uncontrolled
release of pro-inflammatory cytokines, including interleukin (IL)-1, IL-6, and tumor necrosis factor (TNF).
Blockade of IL-1/IL-6 receptor signaling has shown success in treating severe COVID-19, but the molecular cues
initiating excessive production of these cytokines remains unclear. A major source of IL-1 is the inflammasome,
a supramolecular protein complex formed in response to two innate immune stimuli that executes IL-1β release.
Meta-analysis of patient single-cell RNA sequencing data reveals exacerbated expression of IL1B and
inflammasome-related genes in severe, but not mild, COVID-19. Co-culture of primary human airway epithelia
(HAE) and primary human leukocytes during SARS-CoV-2 infection promotes IL-1β release, while infection in
either cell type alone does not. These conditions also promote IL-6 release in an IL-1-dependent manner,
highlighting how inflammasome activation and cell-cell communication amplify this inflammatory response.
Furthermore, infected HAE undergo lytic cell death and secrete inflammasome-activating damage-associated
molecular patterns (DAMPs). Therefore, the scientific goal of this proposal is to understand how SARS-CoV-2
infection promotes pathologic inflammasome responses with the central hypothesis that damage from dying,
infected airway epithelial cells potentiate detrimental IL-1β release. Aim 1 will determine which inflammasome(s)
mediate harmful IL-1β responses during SARS-CoV-2 infection in vivo and identify the tissue(s) from which this
response is derived. Aim 2 will define the mechanism of SARS-CoV-2-mediated cell death in airway epithelial
cells and its relationship with inflammasome-mediated cell death in myeloid cells using an established primary
human co-culture system. Aim 3 will identify DAMPs released by infected primary human airway epithelial cells
that stimulate inflammasome response via an unbiased multi-omics approach. These studies will define how
damage caused by viral infection propagates inflammation and its role in disease, opening avenues for
therapeutic targeting and identifying biomarkers related to pathologic inflammation in COVID-19.
My goal is to become a tenured faculty member at a major research university with a research program
studying fatal and emerging viral pathogens. My group will focus its efforts on understanding the innate immune
response to viruses that regularly threaten human health and pinpoint pattern recognition receptor (PRR) ligands
that lead to detrimental patient outcomes. Using a combined approach of primary human cell culture models,
organismal murine models, and mechanistic molecular biology, I will identify readily translatable molecular
targets to treat human viral diseases. Herein, I outline both a scientific vision and a plan acquire new skills
through collaboration with local faculty, the support of my community and my advisory committee, and formal
coursework to enhance my abilities further, creating a framework for my success as an independent investigator.

Public health relevance
Project Narrative Acute respiratory distress syndrome (ARDS) underlies many COVID-19 fatalities and is linked to uncontrolled production of inflammatory mediators. The goal of this proposal is to understand how lung damage from SARS- CoV-2 infection, the virus that causes COVID-19, promotes this harmful inflammatory response and to identify specific molecules that mediate this response. Mechanistic insight from this work will inform therapeutic design and has broader relevance to all viral pathogens that cause ARDS.